Leveraging Social Media Data and Machine Learning to Optimize Treatment Paradigms for Youth with Schizophrenia

Abstract
Schizophrenia constitutes a chronic and disabling illness. While patients show high rates of response to treatment
after a ﬁrst-episode of schizophrenia, the long-term course of the illness is typically characterized by frequent re-
lapses, persistence of symptoms, and enduring cognitive and functional deﬁcits. Despite the prioritization of
relapse prevention as a treatment goal, about four out of ﬁve patients experience a relapse within the ﬁrst ﬁve
years of treatment. Relapses are known to have serious psychosocial, educational, or vocational implications in
young adults—a population at high risk of psychosis. However, current psychiatric ability to recognize indicators
of relapse in order to prevent escalation of psychotic symptoms is markedly limited. Challenges stem from a lack
of availability of comprehensive information about early warning signs, and reliance on ﬁxed time point sampling
of cross-sectional data as well as patient or family reported observations, that is subject to recall bias, or on clin-
ician sought information, that needs frequent and timely contact. The present proposal seeks to address these
gaps in early psychosis treatment, by leveraging patient-generated and patient-volunteered social media data,
and developing and validating machine learning approaches for “digital phenotyping” and relapse prediction. Our
proposed work is founded on the observation that social media sites have emerged as prominent platforms of
emotional and linguistic expression—young adults are among the heaviest users of social media. The work signif-
icantly advances the research agenda and extensive pilot investigations of the team, who a) have demonstrated
that social media data of individuals can serve as a powerful “lens” toward understanding and inferring mental
health state, illness course, and likelihood of relapse, including among young adults with early psychosis; and
b) have been involved in examining the role of emergent technologies, like social media, in improving access to
and delivery of psychiatric care. Aim 1 will provide theoretically-grounded and clinically meaningful methods for
extracting and modeling digital phenotypes and symptoms from social media data of young adult early psychosis
patients. Then in Aim 2, we will develop and evaluate machine learning methods that will utilize the extracted
social media digital phenotypes to infer patient-speciﬁc personalized risk of relapse, and identify its antecedents.
Finally, Aim 3 will develop a two-faceted validation framework, to assess the statistical and clinical efﬁcacy and
utility of the social media derived inferences of psychosis and relapse in inﬂuencing clinical outcomes and in
facilitating evidence-based treatment. To accomplish these aims, the project brings together a strong multidisci-
plinary team, combining expertise in social media analytics, psychiatry, psychology, natural language analysis,
machine learning, information privacy, and research ethics. Our novel approach offers unprecedented opportuni-
ties to initiate the adoption of personalized, responsive, and preemptive evidence-based strategies in treatment of
psychosis. The knowledge will set the stage for future research on launching large-scale trials aimed to develop
interventions that diminish the severity of relapses, or prevent their occurrence altogether.

Public health relevance
Project Narrative Timely monitoring of symptoms and preventing relapse after an initial psychotic episode are essential component of early intervention programs and have a critical impact on long term outcome in individuals with psychotic dis- orders. Employing patient-contributed social media data as a viable source of collateral information, this proposal provides a suite of robust, scalable, and ﬁeld evaluated machine learning methods to facilitate early and precise identiﬁcation of digital phenotypes, symptomatic exacerbation, and risk of psychotic relapse in early psychosis patients. The knowledge would provide the necessary opportunity to initiate personalized, adaptive, and proac- tive illness management strategies, inform better nosology, and assist the adoption of improved evidence-based care approaches to diminish the severity of relapses, or prevent their occurrence altogether.